Michigan Diabetes Research Center (MDRC)

MDRC Center Overview Project Summary/Abstract
The mission of the MDRC is to promote new discoveries and enhance scientific progress in diabetes, its
complications, and related metabolic disorders through the support of cutting-edge basic and clinical research
by its highly interactive research base. The MDRC research base comprises 148 members with $56.8 million
annual direct cost funding for diabetes-related research (over $80 million including center and training grants):
106 University of Michigan (U-M) members with $42.4 million ($64.9 million including center and training
grants) of annual direct cost diabetes-related funding, plus 42 regional members with $14.4 million of annual
direct cost diabetes-related funding at five nearby Regional Partner Institutions: Michigan State University
(MSU), Ohio State University (OSU), the University of Toledo (UT), the Van Andel Institute (VAI), and Wayne
State University (WSU). The investigators that make up the MDRC research base perform ground-breaking
research in five broad areas relevant to diabetes: Cellular Aspects of Diabetes and Metabolism; Integrative
Aspects of Diabetes and Metabolism; Islet Biology; Diabetic Complications; and Clinical Research in Diabetes
and Metabolism. To support and empower research by its members, the MDRC will:
1. Coordinate activities that raise awareness of, interest in, and support for basic and translational
research in diabetes, its complications, and related endocrine and metabolic disorders at U-M and
beyond.
2. Advance learning and promote scientific exchange related to diabetes, its complications, and related
metabolic disorders.
3. Provide research cores that provide shared, specialized technical resources and expertise that
enhance the efficiency, productivity, and multidisciplinary nature of research performed by MDRC
investigators.
4. Support a Pilot and Feasibility grant program.
5. Provide support for research in diabetes, its complications, and related endocrine and metabolic
disorders at Regional Partner Institutions. The MDRC provides membership, enrichment activities, an
Expanded (Regional) Pilot and Feasibility Grant Program, and access to the MDRC Molecular
Genetics Core for researchers at Regional Partner Institutions who study diabetes, its complications,
and related endocrine and metabolic disorders.

Public health relevance
Project Narrative – MDRC Center Overview The MDRC oversees and provides research cores, enrichment activities and pilot and feasibility grant programs to support and enhance the national research effort related to diabetes. The MDRC promotes new discoveries and enhances scientific progress through the support of cutting-edge basic and clinical research by its highly interactive research base, which comprises 148 members at the University of Michigan (U-M) and regional partner institutions (Michigan State University (MSU), Ohio State University (OSU), the University of Toledo (UT), the Van Andel Institute (VAI), and Wayne State University (WSU).